Generating new mouse mutant strains

During the last year our research core has worked with six NIH research units to generate novel embryonic stem cell lines and new mouse models (12 projects, including 5 CRISPR/Cas9 Zygote injections). This research included establishment of models to study signal pathway interactions in the immune system, T cell development, hematopoiesis, stem cell biology, epigenetic inheritance in the early embryo, mechanisms regulating genomic stability, RNA metabolism, gene regulation and enhancer function, and iron metabolism and malaria risk. We also performed specialized surgeries including thymus implants to support research on immune function.